The bidirectional relationship between brain network dynamics and adolescent alcohol use

PROJECT SUMMARY
There is a high prevalence of risky drinking in adolescents. This is concerning because alcohol use during
adolescence substantially increases risk of eventually developing an alcohol use disorder (AUD). Studies have
begun to show that functional neuroimaging data may be useful for predicting drinking vulnerability in
adolescents. Further, studies show that drinking history is associated with altered functional brain network
architecture in adolescents, particularly in three key subnetworks of the brain (the Default Mode Network
[DMN], Central Executive Network [CEN], and Salience Network [SN]) which together comprise the Triple
Network model. Outside of the adolescent drinking literature, methods for studying time-varying dynamic
functional brain networks (DFNs) have rapidly gained popularity. DFNs depict the second-to-second changes
in functional brain connectivity which have now consistently been shown to support cognitive processes.
Further, DFNs are excellent tools for predicting behavioral and psychiatric outcomes, suggesting that they are
more meaningful models of brain function than regional activation or static functional connectivity. However,
DFNs have never been used to study vulnerability to future drinking nor the effects of drinking on the brain in
an adolescent population. The proposed study will be the first to apply DFNs to studying these two important
topics. I will use a distinct method for analyzing DFNs in each of two aims. In the first aim, I will use sliding
window correlation-based DFNs to predict risky drinking onset in 17-year-old participants of the NCANDA study
using an approach which our lab has previously used to predict success in a behavioral weight loss
intervention with 95% accuracy. In the second aim, I will use Hidden Semi-Markov Models (HSMMs, a novel
method for interpreting brain network dynamics) to assess the longitudinal effect of risky drinking on the brains
of adolescents. My preliminary analyses using HSMMs have shown that individuals who spend more time in
states with strong connectivity between the SN and CEN tend to drink less over the next year of their lives.
This result provides proof of concept that 1) patterns of brain network dynamics are related to future drinking
vulnerability, and 2) the specific method which will be used in the second aim of the proposed project can
successfully identify patterns of brain network dynamics which are relevant to alcohol use. Together, the two
aims in the proposed project will yield novel insights on the biological underpinnings of adolescent alcohol use
vulnerability as well as the effect that alcohol use has on the adolescent brain. We believe that the knowledge
gained from these aims will ultimately help to develop more effective prevention initiatives and provide novel
explanations as to how risky drinking during adolescence can put young people on a pernicious path towards
eventually developing an AUD.

Public health relevance
PROJECT NARRATIVE Alcohol use during adolescence substantially increases risk for developing an alcohol use disorder (AUD) later in life, but relatively little is known about the neural factors which underly vulnerability to drinking during this life stage. The functional neuroimaging field has largely grown towards the study of time-varying dynamic functional brain networks, yet this family of methods have never been applied to the study of adolescent drinking. The proposed project will be the first to investigate the bidirectional relationship between dynamic brain networks and adolescent drinking, including (1) using dynamic brain networks to predict future drinking and (2) studying the impact of drinking history on brain network dynamics.